GLYCOSYL COMPOSITION ANALYSIS OF BIOLOGICAL MATERIALS

These proprietary samples were analyzed for monosaccharide composition by preparing the TMS and alditol acetate derivatives of the methylglycosides, followed by GC and combined GC/MS analyses. TMS methylglycosides were prepared from the sample by methanolysis in 1 M HCl in methanol, followed by N-acetylation with pyridine and acetic anhydride for detection of amino sugars. A treatment with Tri-Sil followed. This resulted in the identification of the monosaccharides by their retention times in comparison to standards; their carbohydrate character was authenticated by their mass spectra.